CDK9-mediated processive transcription in H3K27M+ diffuse intrinsic pontine glioma

PROPOSAL SUMMARY
Diffuse intrinsic pontine gliomas (DIPGs) are aggressive brainstem tumors in children with no curative therapies
available. DIPGs are canonically driven by recurrent mutations in the histone 3 gene (H3K27M). This substitution
imparts broad dysregulation of the histone post-translational modifications (PTMs) that regulate the recruitment
and initiation of transcriptional machinery. Processive transcription, or the mechanics of RNA Pol II as it actively
transcribes across chromatin, is both dependent on and actively propagates chromatin states such as dynamic
accessibility and transcription-associated PTMs (tPTMs). Disorders of transcription dynamics have
demonstrated pathogenic roles in cancer development, and inhibition of transcription machinery is an effective
therapy in these models. We have recently shown that the H3K27M mutation activates regulators of
transcriptional elongation, including CDK9. We have demonstrated that inhibition of CDK9-dependent
transcriptional elongation is an effective therapy in DIPG, but the contribution of processive transcription to DIPG
oncogenic transformation is unknown. The overall hypothesis of this proposal is that the H3K27M mutation
promotes CDK9-dependent nascent transcription, which in turn contributes to both the establishment of an
oncogenic chromatin state as well as the adaptive response to standard-of-care radiation therapy. Using a
combination of CRISPR-edited model systems, patient derived cultures, and both patient-derived xenograft and
syngeneic engineered mouse models, we will test this hypothesis by 1) defining the role of processive
transcription in H3K27M-mediated oncogenesis, 2) determining the impact of CDK9 inhibition on processive
transcription, and 3) characterizing the role of transcriptional induction in response to ionizing radiation.
Successful completion of the proposal will allow us to comprehensively map the impact of the H3K27M mutation
on the nascent transcriptional landscape. This data will enable us to define a novel transcriptional framework for
understanding DIPG’s chromatin-mediated oncogenesis, and it will demonstrate how exploiting this
transcriptional dependence may be leveraged to improve the patient benefit derived from radiation therapy.
The proposed career development plan leverages these studies to provide advanced training in the conduct of
rigorous hypothesis-driven research, the molecular study of transcriptional regulation, and representative pre-
clinical cancer modeling. The mentorship team reflects nationally-recognized senior scientists who possess both
focused expertise in these areas of study as well as a strong commitment to my career development. The training
plan outlines how I will refine my expertise through a combination of didactic course work, focused workshops,
national meetings, and mentorship guidance. Collectively, this training platform will facilitate my transition to
independence as a basic-translational researcher with a long-term goal of applying novel chromatin- and
transcription-based strategies to improve patient outcomes in DIPG.

Public health relevance
NARRATIVE H3K27M-mutant diffuse intrinsic pontine gliomas (DIPGs) are aggressive pediatric brain cancers with no curative therapies available. We have identified a novel DIPG dependency on CDK9, a positive regulator of processive transcriptional elongation. Our proposed characterization of the H3K27M-mediated aberrations in processive transcription will both define a novel framework for understanding DIPG oncogenesis and inform mechanistic understandings critical to the safe translation of CDK9 inhibitors into phase 1 trials for DIPG.